Generation of multilineage adrenal gland organoids using human pluripotent stem cells

ABSTRACT/PROJECT SUMMARY
The adrenal glands (AG) are critical endocrine organs that control the body’s response to stressors, metabolic
challenges, blood pressure changes and immune system regulation. AG disease can be caused by many
ailments, including genetic faults, malignancies and toxins, and both hyper- and hypofunction of the AGs can be
lethal. The AG consists of a core called the medulla that is surrounded by a three-layered cortex, all wrapped in
a capsule. It is known that the AGs develop from progenitors from two independent germ layers, i.e.
ectoderm/neural crest cells giving rise to the AG medulla and mesoderm/intermediate mesoderm giving rise to
the AG cortex. The AG undergoes dynamic cellular homeostasis throughout life driven by adult stem cells located
in the capsule. Several open questions remain about the events leading to proper embryonic development of the
human AGs, about their transformation and dysfunction in human disorders and about normal adult human
homeostasis. Additionally, healthy human AG tissue might become crucial for transplantation approaches for the
future treatment of AG disorders. The lack of a human experimental model system that can mimic the complexity
of the human organ is causing a slow progression in answering such questions. 3D organoids, derived from
human pluripotent stem cells (hPSCs) are ideal to address this gap, however no AG organoids have been
reported to date. Here, we propose the generation of complex, assembled AG organoids from both neural crest
and intermediate mesoderm progenitors. We will characterize the AG organoids in vitro and upon
xenotransplantation based on molecular and functional entities. We will employ the AG organoids to ask
questions about human embryonic development and assess their character on the single cell level. Our AG
organoids will provide a platform to investigate future questions about AG biology and development, AG disease
mechanisms, and ultimately provide the cellular material for cell therapy approaches for AG insufficiency.

Public health relevance
NARRATIVE/RELEVANCE The adrenal glands (AGs) are critical endocrine organs that regulate and maintain homeostasis of the body via a variety of hormones involved in stress adaptation, metabolism and the immune system. Significant advances into the understanding of AG embryonic development, diseases and future treatments are hampered by the lack of a human experimental system amenable to manipulation and scale-up. This project utilizes human pluripotent stem cell technology to generate 3D organoids of the human AG that will enable progress in the understanding and treatment of AG disorders.